COMPUTER SUPPORT FOR CANCER INFORMATION DISSEMINATION

SFI and ISG will provide support for the activities of the Computing and Communication Branch (CCB), International Cancer Research Data Bank Branch (ICRDBB) and the Publications Branch (PB) of the International Cancer Information Center (ICIC), Office of International Affairs (OIA), National Cancer Institute (NCI). Specifically SFI and ISG will provide a Computer Support Center to assist the OIA in the dissemination of cancer information.